CTCF-mediated regulation of partial epithelial-mesenchymal transition states

Project Summary
Cellular plasticity, including epithelial and mesenchymal transition (EMT), whether partial, complete or
reversed, as mesenchymal-epithelial transition-(MET), is critical throughout development and implicated in
wound healing, cancer metastasis, and fibrotic disorders. The reversibility or irreversibility of EMT is critical to
successful implementation of these cellular programs yet is not well understood. We have shown that EMT
results in diminished expression and chromatin interaction of the DNA-binding chromatin looping factor, CTCF.
CTCF has been well characterized as a transcription factor and insulator protein capable of regulating
formation of topologically associating domains (TADs) when bound to CTCF binding sites (CTCF-BSs). TADs
define semi-stable looping structures which can incorporate multiple genes and which impact gene expression.
We have shown that CTCF loss accompanies EMT and yet, paradoxically, causes a more epithelial phenotype
as measured by E-cadherin and N-cadherin expression. Moreover, cells with low CTCF expression respond
differently to TGF-β induced EMT by retaining E-cadherin while still elevating N-cadherin, thus eliciting a
distinct partial EMT state. How CTCF and TADs effect these outcomes is unknown. To achieve our long-term
goal which is to understand the epigenomic impacts on epithelial-mesenchymal plasticity and elucidate
associated mechanistic underpinnings, we propose to test the hypothesis plasticity or irreversibility
between epithelial-mesenchymal states, including distinct partial states, is founded upon dynamic
chromatin looping patterns, driven by withdrawal and re-engagement of CTCF from CTCF-BSs at key
EMT genes. In Aim 1, we will map the EMT-associated redistribution of chromatin loops and TADs, in
combination with gene expression changes, during reversible EMT. We will utilize a model of reversible EMT to
detect and quantify changes in CTCF binding, chromatin looping, and enhancer-promoter interactions using
ChIP-seq and HiC-seq at discrete timepoints. Furthermore, we have uncovered key CTCF engagement sites at
CDH1, CDH2, and ZEB1 with potential regulatory roles for EMT. In Aim 2A: we will determine the functional
outcome of reduced CTCF expression to the phenotype of partial EMT. We will interrogate this hybrid EMT
phenotype by phenotypic analysis including an examination of the relevance of the dual-cadherin state towards
collective and individual cell migration. In Aim 2B: we will delineate the contribution of specific CTCF-BSs
within these loci to chromatin looping and epithelial-mesenchymal plasticity. We will elucidate the mechanism
through a focus on the epigenetic state of these loci by performing 3C-qPCR and ChIP-qPCR at the relevant
loci in timecourse and knockdown models. Overall, we will uncover fundamental mechanisms used by cells to
that have undergone reversible EMT at the level of chromatin looping and TAD distribution. Furthermore, this
work provides opportunities for undergraduate students to perform interdisciplinary research in cellular and
computational biology, while addressing fundamental questions in epigenetics and cellular plasticity.

Public health relevance
Project Narrative Altered cellular differentiation such as during transitions between epithelial and mesenchymal states must be is accompanied by re-organized chromatin to affect gene expression. This work uses a disease-relevant model of altered cellular differentiation to examine the impact of chromatin looping on cellular plasticity. Successful completion of this work will yield new insights on how cells adapt and change in development and various disease states.